The Role of Paid Caregivers in Home-Based Dementia Care

Project Summary
The purpose of this proposal is to better understand factors that determine the roles that paid caregivers
(personal care aides, home health aides, and other direct care workers) play in the home-based care of
persons with dementia (PWD). The progressive functional and cognitive declines of dementia result in
increasing care needs that family caregivers are not always able to meet. Paid caregivers provide help with
not only functional tasks like bathing or cleaning, but also other care tasks like communicating with the
healthcare team and monitoring chronic conditions that support the overall health of PWD. Yet paid caregivers
are usually studied apart from those they care for. The factors that determine paid caregiver roles in the
person-centered dementia care team are unknown. This project has the following research aims: 1) Examine
the association between intensity (type and quantity) of care provided by paid and family caregivers and
adverse consequences of unmet care needs among PWD living in the community over time using data from
the National Health and Aging Trends Study (NHATS); 2) Explore multiple perspectives (family caregiver, paid
caregiver, and medical provider of persons with moderate or severe dementia receiving home-based medical
care) on the factors (e.g. clinical, social, health system, community) that determine paid caregiver roles and
care team interactions over time using longitudinal qualitative interviews; and 3) Elicit key stakeholder
perspectives (e.g. dementia and caregiving advocacy groups, representatives of LTSS and health care
providers) on policy factors that impact paid caregiver roles in dementia care at home and promising practices
to improve paid caregiver integration in the person-centered care team. Employing complimentary research
methods, completion of these research aims will provide key insights into factors that impact ways that paid
caregivers work with family caregivers to provide comprehensive care and inform the policies and practices
that seek to help PWD continue to live at home. In addition, completion of training aims associated with these
research aims will allow Dr. Jennifer Reckrey to become an independent researcher with a broad skill base in
research methodology (dementia research, longitudinal data analysis, qualitative framework analysis method),
policy understanding (knowledge of community-based long-term services and supports and the paid caregiver
workforce), and subject expertise (interdisciplinary research network to advance paid caregiver role in the care
of PWD). With strong mentorship at the Icahn School of Medicine at Mount Sinai, support from a committed
advisory team, and a program of clearly defined training, the proposed project and career development plan
will enable Dr. Reckrey to conduct independent research that guides health policy to maximize the positive
impact of paid caregivers on PWD living at home.

Public health relevance
Project Narrative Paid caregivers (e.g. personal care aides, home health aides, and other direct care workers) provide essential care that allows persons with dementia (PWD) to remain living at home, yet little is known about the lived experience of PWD receiving paid care. This project seeks to better understand factors that determine the roles that paid caregivers play in the home-based care of PWD. This will improve the care for PWD in the community by supporting the meaningful integration of paid caregivers in the person-centered dementia care team and guiding health policy to maximize the positive impact of paid caregivers on the lives of PWD.